Development of a Physical Activity Intervention to Meet the Unique Needs of Sexual and Gender Minority (SGM) Alzheimer's Disease and Related Dementias (AD/ADRD) Caregivers

PROJECT SUMMARY (ABSTRACT)
Candidate: Andrew (Drew) C. Pickett, Ph.D., is an Assistant Professor in the Department of Health & Wellness
Design at Indiana University- Bloomington (IUB). This award will aid his transition toward becoming an
independent investigator in the areas of sexual and gender minority (SGM) health, caregiving for individuals
living with Alzheimer’s disease and related dementias (AD/ADRD), and intervention co-design and evaluation.
Dr. Pickett’s broad research goals seek to develop novel behavioral (e.g., physical activity) interventions to
address health disparities among older adult SGM and caregiving populations. The proposed training plan
develops research-related competencies needed to become an independent aging investigator, including
graduate coursework, trainings, and mentorship related to: (1) SGM aging and health, (2) AD/ADRD caregiving,
(3) and intervention co-design methodologies. Mentors: Co-primary mentor Dr. Richard J. Holden (IUB) brings
expertise and experience in human factors engineering for healthcare management, technology-based
interventions, and AD/ADRD prevention in older adults. Co-primary mentor Dr. Nicole E. Werner (IUB) is an
established, NIA-funded, expert in AD/ADRD caregiving and participatory co-design of technology-based
interventions. The mentorship team also includes four scholars with relevant expertise and extensive
professional networks in areas related to the proposed research. Dr. Jason D. Flatt (UNLV) is an NIA-funded
researcher focused on the understanding health disparities faced by SGM and AD/ADRD populations, with
specific interest on improving health outcomes for vulnerable populations. Dr. Brea L. Perry (IUB) is a health
sociologist with extensive extramural funding history whose research explores the complex interrelationships
between social networks, psychology, and social inequity with health disparities. Dr. NiCole R. Keith (IUI) is an
NIH-funded researcher who brings expertise in health disparities, physical activity, and aging. Dr. Matthew L.
Smith (TAMU) is an established researcher in older adult health, caregiving, and program evaluation. Research:
The proposed research follows the NIH Stage Model to first explore (Stage 0) the unique needs of SGM
AD/ADRD caregivers with respect to physical activity (Aim 1). Drawing on these findings, the research then
proposes to co-design (Stage Ia) a physical activity intervention to meet the unique physical activity needs of
SGM AD/ADRD caregivers (Aim 2). Finally, we propose a feasibility test (Stage Ib) of the co-designed
intervention to measure usability and acceptability across a four-week period (Aim 3). Summary: The proposed
research does foundational work to explore the unique physical activity needs of SGM AD/ADRD caregivers,
given the myriad intersecting challenges they face due to identity stigma and caregiver burden. This project
further seeks to co-design and test a culturally relevant intervention to meet these unique needs. Drawing on
strong mentor support, additional research training, and logistical assistance from professional organizations,
the candidate will gain necessary capacity to ensure successful completion of aims.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE STATEMENT) Sexual and gender minority (SGM) caregivers of persons living with with Alzheimer’s Disease (AD) and AD Related Dementias (AD/ADRD) face complex and overlapping challenges to engaging in regular physical activity (PA), based on identity-related and role-related stressors. Following the NIH Stage Model, this research seeks first to explore unique barriers and facilitators to regular PA engagement faced by SGM AD/ADRD caregivers (Stage 0), then co-design (Stage Ia) and test feasibility (Stage Ib) of a novel intervention to meet these distinct needs. This research will provide timely understanding of unique, intersecting needs of SGM AD/ADRD caregivers and inform creation of a culturally relevant, feasible, and sustainable PA intervention designed to meet specific challenges faced by this vulnerable population.